Mining host-microbe interactions in the neonatal pancreas to combat diabetes

Project Abstract
After birth, newborns are exposed to a wide array of environmental microbes, which rapidly colonize the infant
gastrointestinal tract and then gradually increase in diversity during the first years of the child’s life. Interestingly,
reduced diversity of the resident microbiota can be used to predict Type 1 Diabetes (T1D) onset in genetically
susceptible children, suggesting that early life microbiota diversity is critical in preventing diabetes. Concurrent
with initial colonization and diversification of the microbiota, insulin-producing β-cells undergo essential postnatal
developmental processes. My graduate work showed that zebrafish require intestinal bacteria for post-hatching
proliferation of β-cells. In my postdoc I have gone on to show that germ-free mice also have significant deficits
in β-cell mass and insulin production capacity which can be attributed to loss of microbial stimuli during a specific
window of postnatal life corresponding with β-cell developmental milestones. I have also found that unique
bacteria that are enriched during this time are sufficient to restore β-cell development in germ-free mice.
Therefore, I hypothesize that specific microbes induce neonatal β-cell development and that the lack of microbial
diversity that occurs prior to T1D limits the establishment of neonatal β-cells and reduces the chance to outpace
autoimmune destruction. My background in host-microbe interactions and pancreatic development make me
uniquely poised to address this question and the aims herein will provide me with essential training that will both
advance this project as well as my own career goals. I propose to build upon my existing expertise in
gnotobiology by seeking additional training in immunology and diabetes disease models to address important
immune phenotypes involved in β-cell development and to test whether microbes with effects on β-cell
development can modulate disease severity. This training will add new dimension to my knowledge base that
will be broadly applicable to my goal of leading a lab at a top-tier research institution studying the role of the
resident microbiota in pancreatic health and disease. I believe these avenues of research have the potential to
alter our understanding and approach to pancreatic disease etiologies, and my long-term vision is to develop
novel approaches in the fight against diabetes and pancreatic cancer that will improve the quality of human life.
To ensure I succeed in my endeavor to establish a successful independent lab, I have assembled a team of
supportive faculty mentors who are leading experts in the immunology and diabetes fields. The University of
Utah is matchless for this proposal, as it has a concentration of exceptional researchers who collaborate through
institutional organizations such as the Diabetes and Metabolism Research Center. Since graduate school I have
successfully built collaborations and sought out the expertise that have carrier my ideas herein forward from their
inception. This proposal is no exception, and I plan to develop it into a successful platform in my own lab that
can be harnessed toward the prevention and treatment of diabetes.

Public health relevance
Project Narrative Diversity of the resident microbiota has been shown to be an important factor in the etiology of T1D, a disease characterized by the autoimmune destruction of insulin-producing beta-cells. I have shown that the microbiota is necessary for establishment of a robust beta-cell mass in vertebrates. The goal of my project is to characterize the signaling mechanisms necessary for microbial regulation of mammalian beta-cell development, which I believe will lead to novel therapeutics for the treatment of diabetes.